Indiana Core Center for Clinical Research in Musculoskeletal Health

Advancements in the diagnosis and treatment of musculoskeletal disorders requires a robust
clinical research infrastructure and improved classification of the various disorders. The
overarching goal of the Indiana Core Center for Clinical Research (ICCCR) – the Indiana Center
for Musculoskeletal Health Clinical Research Center (ICMH-CRC) is to provide the needed
training and resources to enhance clinical research in musculoskeletal disorders to improve
musculoskeletal health across a broad range of diseases and populations. In Aim 1 we will deploy
the Administrative Core to facilitate cross disciplinary clinical research by connecting MSK
researchers with investigators studying chronic disease, enhance work with the community to
educate, inform, recruit and assess disadvantaged and minoritized populations, provide pilot
funding, and train the next generation of musculoskeletal researchers. We will innovate through
increased community engagement with racial and ethnically diverse populations to encourage
participation in MSK research. In Aim 2, we will integrate and harmonize big data from multiple
data sources in the Musculoskeletal Informatics Methodology (MIM) Core. We will develop a
facile, secure and innovative MSK Data Mart that integrates and harmonizes 1) The state-wide
“traditional” electronic health record (EHR), 2) Measures of social and structural determinants of
health based on geocoding, 3) The prospective collection of data from the FIT Core, and 4)
genomics and sample availability from the MSK Biobank. The Data Mart will expand our core
linkage and maximize MSK assessment based on the computable (computer data derived)
phenotypes developed and refined during our first P30. In Aim 3, we will foster growth of the
Musculoskeletal Function, Imaging, and Tissue (FIT) Resource Core to provide standardized
assessments of musculoskeletal health and expand the availability of biospecimens to facilitate
exploration of musculoskeletal health and disease. We will innovate our resource Core (FIT Core)
by taking the Core “on the road’ to the community health centers and organizations, diversifying
our tested population to develop race and ethnicity specific Z scores. We will also perform whole
exome sequencing on DNA collected from the participants to expand the utility of the MSK
functional (physical function), morphologic (imaging), and computable (electronic health record)
phenotypes by linking with genomic data. These goals will serve to promote and advance clinical
research in MSK disorders leading to prevention, diagnosis, treatment and cure for ALL
individuals.

Public health relevance
The overarching goal of the Indiana Core Center for Clinical Research (ICCCR) – the Indiana Center for Musculoskeletal Health Clinical Research Center (ICMH-CRC) is to provide the needed training and resources for investigators to enhance clinical research in musculoskeletal disorders across a broad range of diseases and populations.